IND-enabling development for IN-002, an inhaled muco-trapping mAb against respiratory syncytial virus

Project Summary
Respiratory Syncytial Virus (RSV) is the leading cause of viral death in infants and young children, and is
also a major cause of respiratory illness in immune compromised adults and the elderly. Unfortunately, there is
currently no vaccine or effective therapy available for RSV. Synagis, a monthly intramuscular injection of the
monoclonal antibody (mAb) palivizumab, is the only FDA-approved intervention, but can only be used for
prevention and is given only to a very small subset of high-risk infants. Synagis is not effective at treating RSV
after infection has begun. Thus, for the tens of thousands hospitalized with RSV, only supportive therapy is
available; the resulting morbidity and mortality are substantial, particularly among the immunocompromised.
Interestingly, RSV spreads in the lung via shedding of virus exclusively into the airway; thus, RSV must
traverse the airway mucus (AM) before infecting other neighboring cells, and remains restricted to the airways
with little-to-no systemic viremia. This unique pathophysiology makes RSV difficult to target by systemically
dosed therapies. We believe an RSV-specific, safe and effective antiviral therapy that can be inhaled directly
into the respiratory tract would provide a powerful option addressing the current gap in pharmacological
interventions. To meet this goal, Inhalon has been advancing IN-002, developed using its proprietary and
patented “muco-trapping” mAb technology platform. IN-002 is a potent anti-F mAb with picomolar binding
affinity and neutralization potency, has minimal risk of viral escape, and possess suitable Fc N-glycosylation for
trapping RSV in AM. In turn, trapped RSV are quickly purged from the airways via natural mucociliary
clearance mechanisms. We have further formulated IN-002 to be stably nebulized using a vibrating mesh
nebulizer. By concentrating IN-002 directly at the site of infection, rather than delivering the mAb systemically,
we expect to enable efficacious and cost-effective treatment of RSV, with little risk of adverse side effects due
to limited systemic adsorption from pulmonary delivery. In a neonatal lamb model of RSV infection, daily
nebulized therapy with IN-002 initiated even at near peak viral titers in the lung was able to reduce infectious
RSV viral load in the lungs and BALF to almost non-detectible levels within 3 days. Inhalon is currently actively
engaging in cell line development for IN-002. To enable rapid translation into the clinic, we seek to complete
the cell line development in this proposal, and produce tox materials suitable for IND-enabling activities such
as Tissue Cross Reactivity studies, GLP pulmonary tox studies, and GLP nebulization characterization studies.
Together, the proposed work will support rapid advancement of IN-002 into clinical testing. Our work here with
RSV will also help pave the way for improved, molecularly-targeted, inhaled therapies for other respiratory
pathogens.

Public health relevance
Project Narrative There is no vaccine or treatment available for Respiratory Syncytial Virus (RSV), the most common viral infections and leading cause of viral infection mediated hospitalization in young children, with millions of infections and tens of thousands of hospitalizations each year in the U.S alone. To meet the urgent need for an RSV treatment, Inhalon is advancing IN-002, a monoclonal antibody against RSV that can be stably nebulized and rapidly clear RSV from the lung airways. This Phase II proposal will support IND-enabling activities that are part of the critical path to advancing this promising treatment into clinical study.